Eukaryotic Initiation Factor 2a Signaling in Dystonia Pathogenesis and Treatment

ABSTRACT Dystonia, a debilitating movement disorder characterized by sustained and painful involuntary postures, is the 3rd most common movement disorder yet very little is known about its biological cause. Currently, only symptomatic treatments are available, which have limited efficacy, significant side effects, and are often invasive or require access to specialized facilities. Early-onset torsion dystonia (DYT1), the most common inherited form of dystonia, is a severe, childhood-onset form of the disease. Recently, our lab conducted a whole-genome RNAi screen using a novel assay of DYT1 cellular pathology, which identified Eukaryotic lnitiation Factor 2α (elF2α) signaling as the most highly enriched pathway. ln subsequent experiments, our lab showed that a compound which enhances elF2α signaling improved the DYT1 cellular pathology and a compound which inhibits elF2α signaling worsened the pathology in a dose-dependent manner, indicating that enhancing elF2α signaling is protective against DYT1 and vice versa. DYT1-isogenic model mice are deficient in a synaptic process known to require elF2α signaling and fibroblast cells derived from DYT1 patients display decreased elF2α signaling in response to stress stimulation, suggesting that elF2α signaling is deficient in DYT1 in vivo. Furthermore, mutations in both an upstream activator and a downstream effector of elF2α signaling are found in patients with other forms of dystonia, suggesting that defective elF2α signaling is critical in non-DYT1 dystonia pathogenesis as well. Therefore, l hypothesize that deficient elF2α signaling is a critical mediator of dystonia pathogenesis and that pharmacologically enhancing elF2α signaling will have therapeutic effects in animal models of dystonia. Here l propose to: 1) Determine how elF2α signaling is disrupted in DYT1 by a) measuring neuronal elF2α signaling in wild type and DYT1 model mice and b) determining how the DYT1-causative mutation leads to deficient elF2α signaling. 2) Determine if enhancing elF2α signaling reverses a synaptic plasticity deficit in DYT1 model mice using slice electrophysiology. 3) Determine if inhibiting elF2α signaling is sufficient to cause dystonic phenotypes in wild-type mice, either alone or in conjunction with environmental stress.

Public health relevance
NARRATIVE Dystonia is the third most common movement disorder, but very little is known about its pathogenesis and current treatment options are very limited. This project will advance scientific understanding of the origins of dystonia and identify molecular targets which may lead to novel dystonia pharmacotherapies.